Center for Public Information on Population Research

Project Summary/Abstract PRB will create a Coordinating Center for the NICHD Population Dynamics Centers Research Infrastructure Programs to improve the translation and dissemination of major findings from population dynamics research, and to improve communication and cooperation across the Centers. The Coordinating Center will accomplish these objectives through a complementary set of activities: 1) Developing an All-Centers website that includes concise, nontechnical summaries of recent research funded by NICHD's Population Dynamics Branch (PDB) that are promoted through social media; 2) Establishing a Coordinating Center Advisory Committee and arranging the annual grantee meeting of the Population Dynamics Centers PD/PIs with NICHD program officials; 3) Creating a standardized reporting template for the Centers to share program results, productivity, and plans with each other and with NICHD program officials; 4) Empowering Population Dynamics Centers researchers to publicize and translate their own research for policymakers and journalists through training activities and resources; and 5) Evaluating the success and impact of Coordinating Center activities through web performance measures, A/B testing of email campaigns, and feedback from Population Dynamics Centers Directors and researchers through in-person and virtual meetings, and online surveys.

Public health relevance
Project Narrative A Coordinating Center for the NICHD Population Dynamics Centers Research Infrastructure Programs will improve the translation and dissemination of major peer-reviewed findings from population dynamics research to multiple audiences, facilitating the adoption of relevant findings for health research and practice. It will also improve synergy across the Population Dynamics Centers, enhancing the productivity and scientific impact of the Centers and of population dynamics research overall.